GRAY MATTER DENSITY IN PATIENTS WITH TYPE 2 DIABETES AND MAJOR DEPRESSION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We are using cortical mapping techniques to measure changes in gray matter density in subjects with type 2 diabetes and major depression.